Adapting the Public Health Disease Intervention Specialist (DIS) Model for Proactive Substance Use Disorder (SUD) Intervention

Project Summary
There is a critical need to intervene with individuals affected by substance use disorder (SUD) earlier in their
trajectory, even before they present to a location where screening or care could be possible. Rapid diagnosis
and linkage to treatment (secondary prevention) is a cornerstone of any epidemic response but often very
delayed for SUD. For communicable infectious diseases (ID), health departments employ disease
intervention specialists (DIS) skilled in outreach to underserved and disproportionately affected populations
identified via social contacts, who once located, disclose their own contacts, yielding “snowball” chain-referral
for the most direct, rapid, and proactive approach to identify affected, but undetected, populations. SUD also
exists within social networks and substance exposure spreads like contagion, but the DIS paradigm has
not been adapted to the problem of SUD. With support from Funding Option B (develop, implement, and
rigorously evaluate strategies), we will (AIM 1): Develop and implement promising operational models for
adapting the conventional ID DIS model to provide secondary SUD prevention: In close collaboration with
health department partners, we will create three service models: 1) Overlay of SUD intervention on current ID
DIS: systematically screen clients (already being identified by ID diagnosis or exposure) for concurrent SUD; 2)
SUD DIS: SUD specific DIS elicit social contacts with potential SUD from index clients with SUD who are
identified in collaboration with other local service agencies; and 3) SUD DIS with peer-support: Peers
embedded with the SUD DIS team. Model 1 will be operated separately from the SUD DIS program, with
randomization by day to Model 2 or 3. In all 3 models, DIS will provide secondary prevention to those SUD
screen+ (i.e., high risk score on NIDA-Modified ASSIST) and not already in care. (AIM 2): Rigorously evaluate
models for incorporating SUD prevention into DIS programs. We will compare program-level outcomes
using (i) data from DIS records, (ii) summary intake counts from regional SUD treatment centers, (iii) time and
motion observations of DIS activities, and (iv) qualitative interviews with stakeholders (clients and staff) about
the DIS program. We will also prospectively observe clients (n=400 each DIS program, for total n=1200)
receiving DIS intervention who consent to research to enable comparison of the effectiveness of SUD
secondary prevention provided by the different DIS program models. Assessment: Self-report at baseline
(0),1, and 6 months, complemented by review of health records (via release of information) and vital statistics
(i.e., mortality). Primary Outcome: severity of drug use at 6 months post initial DIS interview. Key Secondary
Outcomes: participant characteristics; healthcare/service utilization; alcohol use; and overdose. This
innovative, high-impact investigation will be the first to use this well-established public health approach,
capitalizing on social networks, to offer early and more specifically targeted secondary prevention for SUD.
Results will vastly improve public health practice, program planning, policy, and future intervention.

Public health relevance
Project Narrative The overdose crisis demands the most intensive public health strategies available. We will adapt the health department Disease Intervention Specialist (DIS) model, used for nearly a century in response to epidemic infectious disease, to the problem of substance use disorder. The impact of this proposal will be to expand the volume and intensity of secondary overdose prevention by accelerating identification of people at-risk and proactively linking them to evidence-based treatment.